Neurodevelopmental Disorder Risk Gene Regulation of Intrinsic Membrane Excitability: A Rheostat that Tunes Dendritic Morphogenesis to Regulate Circuit Assembly During Development

Project Summary
The goal of this project is to understand how gene expression during development shapes the delicate and
massively parallel cell biological processes that promote wiring of functional networks within the cerebral
cortex. This is an important area of basic research because neural dynamics within cortical networks are the
direct correlates of thought and behavior. These cognitive processes emerge as neural circuits form through
expression of genes over the course of development. Moreover, cognitive impairment, which defines
neurodevelopmental disorders (NDDs), is thought to arise, at least in part, from impaired neural circuit
connectivity within the developing cortex. A revelation over the past decade is that NDDs can be caused by de
novo genetic loss-of-function SNVs within a single gene. Thus, in-depth study of natural functions of these
genes can reveal the neurobiological principles underlying the typically developing cortex and as well as
principles that contribute to abnormal cortical development associated with NDDs. In this project, we will
explore the hypothesis that expression of NDD-associated genes in the typically developing cortex promotes
the assembly of cortical circuits through cell-autonomous regulation of intrinsic membrane excitability. This
hypothesis is significant because it is known that neural activity shapes the assembly of developing cortical
circuits. However, it remains unknown how genes function at the cellular level to promote activity-dependent in
vivo development of cortical circuit motifs known to promote cognitive function and behavioral adaptations. Aim
1 will explore the causal relationships between genetic control of intrinsic membrane excitability (IME), activity-
dependent dendritic morphogenesis, and developmental assembly of cortical circuits. Aim 2 will explore causal
links between genetic control of IME, neuronal ensemble structure/function, and behavioral adaptations. We
will do this by regulating genetic control of IME in developing cortical neurons and then observing the effect of
this on cortical ensembles and behavioral adaptions. This research design is important because the brain
functions across multiple temporal and spatial scales – indeed, this project attempts to link gene function
across the major levels of brain function – gene>neuron>synapse>circuit>ensemble>behavior. The overall
impact of this proposed research is that it has the potential to reveal how gene expression shapes the activity-
dependent assembly of neural circuits that promote cognitive functions required for behavioral adaptations.
Because we focus on natural functions of an NDD gene, these basic insights are also directly relatable to the
etiology of cortical wiring impairments associated with childhood brain disorders.

Public health relevance
Narrative Cognitive processes emerge as neural circuits form through expression of genes over the course of development, though it remains unknown how genes function at the cellular level to promote activity- dependent in vivo development of cortical circuit motifs known to promote cognitive function and behavioral adaptations. The impact of this proposed research is that it has the potential to reveal how gene expression shapes the activity-dependent assembly of neural circuits that promote cognitive functions required for behavioral adaptations.